Dissecting the modulatory functions of interleukin-17 in Alzheimer's Disease

ABSTRACT
Alzheimer’s Disease (AD) is one of the most common causes of dementia, affecting over 5 million elderly
patients in 2020. The affected patient number will likely grow in the United States and reach 10 million by 2040,
representing a significant challenge to public health care. It is thus imperative to find novel ways that offer
mechanistic insights into the onset and the progression of AD. While a growing body of evidence indicates the
critical function of innate immune systems in AD, relatively few studies investigated mechanisms by which
adaptive immune cells contribute to the pathogenesis of AD.
Along with genetic factors, environmental factors are critical contributors to driving neurodegenerative
disorders, including AD. Gut microbes, which have been extensively studied for their roles in shaping the host’s
immune function, are being recognized as one of these non-genetic factors that define a threshold to either
maintaining homeostasis or developing diseases. Intriguingly, AD patients often display gut dysbiosis,
suggesting that the make-up of gut-residing bacteria may affect the development and progression of AD. While
many studies in recent years have shown that gut-residing bacteria and immune cells affect brain function, the
underlying mechanisms by which gut bacteria empower peripheral immune cells to influence AD-related
phenotypes are unknown.
Among the many immune cell types, Th17 cells are uniquely positioned to relay signals from gut-residing
bacteria to the brain. These cells are induced in the gut mucosa in response to a commensal bacterium and can
migrate into the meninges. We and others have also shown that a receptor for IL-17a, namely IL-17Ra, is
expressed in the adult brain and facilitates the communication between the immune and nervous systems.
In
the proposed application, we will assess the contributing roles of the triad of gut bacteria-peripheral Th17
cells-brain IL-17Ra in promoting AD-related pathologies and cognitive decline. We will first identify the role
of IL-17a-producing cells in promoting AD-related pathogenesis and determine the contributing roles of gut-
residing bacteria that enhance Th17 cell biogenesis in the development of AD. Second, we will uncover the
underlying mechanisms by which IL-17a affects brain cells during AD development.
Successful completion of this study will likely lead to future human studies identifying preventive and
therapeutic measures, such as probiotics or blocking antibodies, to suppress the IL-17a responses in patients
with a high risk of developing AD-related cognitive decline.

Public health relevance
NARRATIVE Our proposal will examine the mechanisms by which interleukin-17a response contributes to Alzheimer’s disease (AD). We will also assess if gut-residing bacteria affect this process by impacting the adaptive immune response. Successful completion of our proposed work will provide mechanistic insights into the roles of specific immune cells in AD and offer ways to design measures, such as probiotics and therapeutic antibodies, to mitigate symptoms among AD patients.